Coronary artery dysfunction in OSA: Role of mineralocorticoid receptors

Abstract
Obstructive sleep apnea (OSA) is a prevalent condition worldwide, especially in people with obesity, and is an
independent risk factor for cardiovascular disease (CVD), including coronary microvascular dysfunction (CMD).
Current available OSA treatments have not consistently detected the anticipated improvements in CVD and
CMD, suggesting the need for adjuvant therapies aimed at the mechanisms underlying the core disturbances
induced by OSA. As such, OSA-induced renin-angiotensin-aldosterone system (RAAS) activation may trigger
excessive mineralocorticoid receptor (MR) signaling, which play a major role in endothelial dysfunction and
atherosclerosis. Thus, the hypothesis is that OSA-induced CMD is mediated, at least in part, by MR dependent
mechanisms. To examine the role of MR in OSA-induced CMD, obese C57Bl/6 male and female mice will be
exposed to intermittent hypoxia (IH) during the rest period, a mouse model of OSA, for 6 weeks (short-term) and
16 weeks (long-term) and treated with the conventional steroidal MR antagonist (spironolactone) or the novel
non-steroidal MR antagonist (finerenone) to evaluate the MR-dependent reversibility of IH-induced CMD (SA1).
To investigate whether MR inhibition can accelerate CMD recovery, mice will be exposed to short-and long-term
IH followed by 12 weeks of normoxia (IH cessation – simulating ideal OSA treatment) with or without concurrent
treatment with MR antagonists (SA2). To examine the role of vascular cell-specific MR, transgenic mice with
endothelial cell (EC)-specific and smooth muscle cell (SMC)-specific deletions of MR will be exposed to long-
term IH (SA3). Coronary artery function will be evaluated in vivo and ex vivo in addition to heart function, blood
pressure and metabolic assessments. Moreover, immunohistological analysis of the coronary vessels, along
with gene networks expression dynamics among different coronary artery cell populations will be evaluated using
single-nucleus RNA sequencing (snRNA-seq). Male and female mice will be fed a high-fat or control diet for 8
weeks then housed in environmental chambers for IH exposures (alternating 6.1% FIO2/21.0%FIO2 90 sec:90
sec, for 6 or 16 weeks during 12 daylight hours, and treated with spironolactone (20mg/kg), finerenone (1mg/kg),
or placebo. IH cessation protocol consists of removing the exposed animals for the IH chambers and left under
normoxic conditions for 12 weeks. Heart function will be examined via echocardiography, while blood pressure
and coronary flow reserve velocity (CFVR) will be assessed using tail cuff method/telemetry and doppler flow
velocity system, respectively. Additionally, Insulin tolerance test and fasting blood and lipid profiles will be
evaluated. After euthanasia, coronary arteries will be excised and mounted on a wire myograph for functional
studies or processed for immunohistological analyses (including intima-media thickness, collagen fiber
distribution, and indices of oxidative stress and inflammation) or snRNA-seq. The proposed studies will elucidate
the role of MR signaling in OSA-mediated coronary artery dysfunction and potential approaches to enhance
CMD reversibility, thereby enabling MR antagonists as biologically plausible therapeutic targets in OSA patients.

Public health relevance
Project Narrative Obstructive sleep apnea (OSA) is a chronic condition that can lead to heart attacks. The currently unknown impact of OSA on the coronary arteries of the heart in female and obese OSA patients and the contribution of mineralocorticoid receptor activation, which is known to cause cardiovascular disease, will be characterized using a mouse model of sleep apnea. This will permit development of treatments for OSA patients to prevent coronary heart disease